Development of a B Cell Based Vaccine for the Treatment of Newly Diagnosed Malignant Gliomas

PROJECT 3: SUMMARY
Immunotherapy has significantly improved the clinical outcome of many cancer patients. However, most glioblastoma
(GBM) patients have not, so far, benefited from immunotherapeutic intervention. To explore alternative ways to
potentiate the anti-GBM immunity, we've developed a B-cell-based vaccine (BVax) that consists of 4-1BBL+ B cells
activated with CD40 agonism, BAFF, and IFNg stimulation. In our preclinical study, BVax migrates to critical secondary
lymphoid organs and is proficient at antigen cross-presentation, promoting the survival and functionality of tumor-
infiltrating CD8+ T cells. In addition, BVax produces immunoglobulins (humoral immune response) reactive to the tumor.
These immunoglobulins elicited a potent therapeutic effect. A combination of radiation, BVax, CD8 T cells and PD-L1
blockade conferred tumor eradication in 80% of treated tumor-bearing animals. This research proposal aims to translate
BVax to the clinic to treat newly diagnosed malignant gliomas. To effectively implement this therapy in the clinic, we
propose to perform IND-enabling studies to manufacture autologous BVax and CD8 T cells (Aim 1). Upon FDA approval,
we aim to conduct a first-in-human BVax trial (Aim 2) and evaluate the effect on the immune response (Aim 3). We
hypothesize that the proposed autologous cellular therapy is safe and effective at eliciting protective anti-GBM immunity
via cellular and humoral immune responses. Overall, our study provides a novel alternative to current
immunotherapeutic approaches.

Public health relevance
PROJECT 3: NARRATIVE Immunotherapy is a promising approach to treating cancer patients, yet its efficacy so far has been very limited in patients with high grade gliomas. Our work provides an opportunity to explore the B-cell-based vaccine (BVax) as immunotherapy. Our approach utilizes 4-1BBL+ B cells as a cellular platform to promote anti-tumor immunity. This innovative strategy utilizes inherent B-cell effector functions such as antigen presentation and subsequent T-cell activation (cellular immunity), and production of tumor-reactive antibodies (humoral immunity). The preclinical BVax proved to be highly efficient at eradication the tumor in mice. The proposed research project aims to take BVax from the bench and translate it to the clinic.